ELECTROPORATION SYSTEM FOR ADHERENT CELLS

The use of electrical discharges in research laboratories for electroprating suspension and adherent cells is growing. Conventional processess for electroporating cells, however, are not readily adapted to different formats or high volume throughput. The proposed process for electroporating adherent cells promises to reverse this trend. New, low cost materials will be used to construct electroporation chambers that can be easily adapted to many different formats ranging from 96-well culture dishes to large-scale bioreactors. PROPOSED COMMERCIAL APPLICATION: The proposed research will lead to the development of several new products for performing electroporation experiments. The products which will be designed to interface with existing electroporation power supplies, are anticipated to fill the need for increased utility and lower cost products.